Characterisation and harnessing the CD8+ Tissue Resident Memory T cell response in HPV-driven anal neoplasia.

Project Summary
Anal cancer has a rising incidence in the Americas, Australia and parts of Europe, the major risk
factor being high-risk human papilloma virus (HR-HPV). However, when a precancerous high-
grade squamous intraepithelial lesion (HSIL) develops in HIV-infected hosts only a minority
progresses to anal cancer in the absence of treatment, highlighting the existence of effective
host immune surveillance. Our project endeavours to define the mucosal T cell mechanisms
controlling HSIL progression and harness for novel therapeutic development.
We leverage from the successful natural history Study of the Prevention of Anal Cancer
(SPANC), that recruited HIV-infected uninfected adult men who attended 6 clinic visits over 3
years. Archived tissue sections of patients with SIL together with an existing rich clinical
database represents a significant translational research opportunity.
Tissue resident memory T (TRM) cells are specialised lymphocytes adapted for life in tissue, with
minimal re-circulation. CD8+ TRM cells are characterised by co-expression of CD103 and CD69
and high expression of inflammatory and cytotoxic markers. There is exciting emerging data for
their role in anti-tumour immunity, including in HPV-associated head and neck squamous cell
carcinoma (SCC), where the proportion of tumour-infiltrating CD8+ TRM cells positively correlates
with prognosis and survival.
AIM 1: To quantify total and activated tissue CD8+ TRM cells in HPV16+ and HPV16- SIL and
determine if HIV-co-infection has an impact on the size, distribution and phenotype of
these populations.
AIM 2: To define the molecular characteristics of both the T cell rich zones and stroma of
patients with regressive versus persistent high grade HSIL. To determine if the presence
of HIV co-infection modulates the expression of these biological pathways.
AIM3: To identify novel therapeutic targets that activate CD8+ TRM cells e.g.
established or emerging checkpoints PD-1, CTLA-4, LAG-3, CD39 and/or cereblon.
This will be the first comprehensive study of TRM cells in anal cancer pathogenesis and the first
to examine the effect of co-morbid HIV infection. We will define the role TRM cells play in HSIL
regression using cutting-edge multi-plex spectral microscopy, Digital Spatial (RNA) Profiling and
single-cell protein-RNASeq, providing a sound foundation for advancements of novel
therapeutics development aimed at decreasing the significant burden of this disease.

Public health relevance
PROJECT NARRATIVE Human immunodeficiency virus (HIV) exists for the duration of natural life within infected people and can affect how we are able to fight other viral infections. This study will accurately tell us how well equipped our immune system is to prevent cancer caused by human papillomavirus (HPV), when infected with HIV at the same time. We will learn how a particular set of immune cells, tissue-resident memory T-cells, work at the place where HPV infects the body to inform the design of future therapies.